Elucidating the interplay between H3K27M variants and DNA damage repair in diffuse midline glioma

Project Summary:
Diffuse midline gliomas (DMG) are rare and fatal brain tumors arising in young children. The past 50 years have
seen few therapeutic advancements; the only approved therapy for DMGs remains ionizing radiation (IR)
therapy. Genomic profiling of DMGs revealed that they are driven by K27M mutations in the genes encoding
either the canonical Histone 3 (H3.1) protein or its variant H3.3, core members of the nucleosome complex that
regulates genome organization. However, H3K27M mutations are insufficient to drive DMG formation as single
alterations and must occur conjuction with secondary alterations. Nearly all DMGs have mutations that inactivate
p53, however the mode of inactivation varies between tumors. Additionally, H3.1K27M and H3.3K27M define
separate subsets of DMGs, with distinct downstream molecular alterations. Our group showed that H3.3K27M
DMGs have frequent TP53 mutations, which completely ablate p53 function, and exhibit significant genomic
instability, with frequent and complex structural variants (SVs) – which result from errors double-stranded DNA
break (DSB) repair. In contrast, H3.1K27M DMGs are enriched for alterations that partially inhibit p53 and are
more genomically stable. The overarching aim of this proposal is to test whether H3.1K27M and H3.3K27M
differentially alter p53 activity and promote tolerance of DNA-damage through different mechanisms, and
whether this process creates vulnerabilities that can be targeted using novel therapeutic approaches. In Specific
Aim 1, I will test whether the differences in genomic stability between H3.1K27M and H3.3K27M DMG subsets
are explained by differences in mitotic stability produced by the mutations. I hypothesize that H3.3K27M
expression predisposes cells to mitotic errors, resulting in increased rates of DSBs and SV formation in this DMG
subset. In Specific Aim 2, I will test whether the high frequency of p53 loss in H3.3K27M DMGs is due to
selective pressures induced by H3.3K27M expression. I hypothesize that H3.3K27M expression induces p53
activity and leads to cell cycle blocks. Therefore, cells expressing H3.3K27M would experience a strong selection
pressure to inactivate p53, thereby increasing genomic instability in the resulting tumor. In Specific Aim 3, I will
test whether p53-reactivation therapy is a viable strategy in DMGs that are wild-type for p53 itself, and will
evaluate whether MAPK inhibition synergizes with p53-reactivation to increase the efficacy of therapy and
circumvent the development of therapeutic resistance. I hypothesize that p53 reactivation engenders a
compensatory dependency on MAPK signaling that can be therapeutically targeted in DMGs. Taken together,
these aims will test the overlying hypothesis that H3.3K27M and H3.1K27M lead to differential responses to DNA
damage and p53 inactivation. The information generated from these aims will provide a profile of the pressures
driving early tumor evolution in DMGs, and may provide potential therapeutic strategies to target p53 or increase
the efficacy of existing DSB-generating therapies like ionizing radiation.

Public health relevance
Project Narrative: Diffuse Midline Gliomas (DMGs) are uniformly fatal pediatric brain cancers with distinct molecular subsets defined by which variant of the Histone 3 protein (H3.1 vs H3.3) acquires the oncogenic K27M alteration. This proposal will investigate how H3.1K27M and H3.3K27M differentially alter DNA damage tolerance, mechanisms of p53 inactivation, and sensitivity to p53-reactivation therapy. Given that current standards of care involve using ionizing radiation to induce DNA-damage, an increased understanding of mechanisms of response to DNA damage in DMGs will provide an avenue for novel therapies and improved therapeutic responses to existing therapies.